Renal Microvessel Imaging for Characterization of Chronic Kidney Disease

PROJECT SUMMARY
Chronic kidney disease (CKD) is estimated to affect 30 million Americans and incur healthcare cost of $30.9
billion every year. There is an urgent need of a safe and noninvasive clinical tool for accurate staging of CKD,
which is essential for its management. The importance of renal parenchyma perfusion and vasculature
morphology for CKD characterization has been documented by many studies, but is not used clinically due to
lack of translatable imaging solutions. In this project, we will use a novel super-resolution ultrasound imaging
(SRUI) technology, which can resolve 50-micron renal cortex microvessels and measure their blood flow speed
in human, to quantify cortex microvessel morphology and perfusion for accurate CKD characterization.
Aim 1: Technical development. New acquisition and processing methods will be developed to enhance
performance of SRUI through phantom and patient experiments. Novel quantitative parameters of SRUI for
renal cortex will be developed, which includes vessel density, diameter, and tortuosity, as well as mean blood
flow velocity, micro- Resistive Index of arterioles and venules, and perfusion index.
Aim 2: Animal validations. We will study 7 normal pigs and 14 CKD pigs with renal artery stenosis (RAS) to
validate SRUI measurements using independent measurements obtained through contrast enhanced CT,
micro-CT, and histology.
Aim 3: Clinical study. We will study 50 healthy volunteers to establish the normal range of SRUI parameters
and study 116 CKD patients with clinically indicated renal biopsy to investigate the efficacy of SRUI for CKD
staging, using biopsy histology as the reference standard. Statistical difference between CKD patients and
healthy controls and differences across CKD stages defined by histology will be evaluated. The association of
each ultrasound parameter with histology CKD score will be assessed. Univariate and multivariate logistic
regression and ROC analyses (receiver operating characteristic) analyses will be performed to assess the
performance of SRUI, conventional ultrasound (renal length, cortex thickness, Doppler renal resistive index,
and shear wave elastography), and clinical parameters (eGFR and proteinuria) for distinguishing histology
CKD stages. A subset (N=45) of patients will be scanned by two sonographers randomly selected from a pool
of five sonographers. Intraclass correlation coefficients will be used to evaluate the inter-sonographer
agreement. The inter-sonographer variance will be calculated to estimate the minimum detectable difference
for longitudinal follow-ups.
Successful completion of this project will result in a safe, noninvasive, cost-effective, and accessible ultrasound
technology for accurate characterization of chronic kidney disease to guide treatment decision making.

Public health relevance
PROJECT NARRATIVE About 30 million Americans are estimated to have chronic kidney disease, which incurs healthcare cost of more than $50.4 billion annually. Accurate characterization of chronic kidney disease is essential for its management. In this study, we will develop and test a new ultrasound technology for safe, cost-effective, convenient, and accurate characterization of chronic kidney disease.